Skin probiotics to treat Netherton Syndrome

Project Summary
Netherton syndrome (NS) is a genetic disorder of significant severity impacting the skin, hair,
and immune system. The condition arises from mutations within the SPINK5 gene, responsible for
encoding LEKTI (Lympho-epithelial Kazal-type inhibitor), a serine protease inhibitor. Ordinarily, the skin's
exfoliation process is modulated by the balance between these serine proteases and their inhibitors.
Mutations in LEKTI lead to elevated serine protease activity, leading to the persistent skin condition
associated with NS. Unfortunately, an FDA-approved therapy remains absent for this condition, with
management of symptoms primarily relying on antibacterials, emollients, and corticosteroids. Most
therapeutic efforts are to develop small molecule inhibitors, but systemic absorption of these long-
lasting molecule often results in toxicity.
We propose to genetically engineer a harmless bacterium to temporarily populate the skin and
deliver LEKTI fragments, that normally have a short half-life, continuously. In our Phase I SBIR, we
established the safety and feasibility of our topical application. In this Phase II application, we fully
develop our final cell therapy and show efficacy in diseased in vitro and murine models. This data will
provide the crux of our pre-IND (Investigational New Drug) meeting with the FDA. Our platform for
continuous production of peptide drugs on the skin surface has the potential to revolutionize the
treatment of NS.

Public health relevance
Project Narrative Netherton syndrome (NS) is a rare hereditary disorder that results in skin, hair, and immune abnormalities due to insufficient activity of LEKTI (Lympho-epithelial Kazal-type inhibitor), a serine protease inhibitor. This project extends the proof-of-concept studies of an engineered bacteria that treat NS through continuous delivery of LEKTI fragments to illustrate efficacy in in vitro and murine models. This project will bring the lead therapy to the cusp an IND application, potentially transforming the well-being of NS patients.